Identification of progenitor CD4 T cells that support response to chronic antigen

Abstract
Durable immune response by both CD4 and CD8 T cells is required for the control of chronic infection or
tumors. In the past few years, multiple independent studies have identified a subset of progenitor-like or stem-
like TCF-1+ PD-1+ CD8 T cells in both chronic viral infections and tumors. These progenitor CD8 T cells
continue generating new effector CD8 T cells to support long-term CD8 T cell responses to persisting antigens
(Ags). They are also capable of eliciting robust effector responses by the immune checkpoint blockade
targeting the PD-1 to PD-L1 interaction. However, it remains unknown how CD4 T cell responses to persistent
Ag are maintained, or whether a specialized subset of progenitor-like CD4 T cells equivalent to TCF-1+
progenitor CD8 T cells exists to support the durability of CD4 T cell response or respond to the PD-1 blockade.
We have found that the transcription factor BCL6 is essential for the durable CD4 T cell effector response to
chronic LCMV infection, implying that an analogous progenitor CD4 T cells are present in the face of chronic
antigen stimulation. We propose to identify such a CD4 T cell population and conduct the initial
characterization of the unique CD4 T cell subset.

Public health relevance
Project Narrative CD4 T cells play central roles in controlling adaptive immune responses, such as antiviral and anti-tumor immunity. Whereas CD4 T cell differentiation in response to immunization with soluble protein or in the context of acute pathogen infection has been well studies, their responses to persistent antigen in tumors or during chronic viral infection are not well understood. In this proposed study, we will define the cellular mechanisms by which antiviral CD4 T effector responses are durably maintained in the context of chronic viral infection.